Implementation of U.S. Food Safety Modernization Act - Identifying, Researching, and Implementing Alternative Methods to Expand the Reach across the Global Supply Chain

Project Abstract - IICA
With this current proposal, the Inter-American Institute for Cooperation on Agriculture (IICA) seeks to
build on previous successes and implement high-impact interventions that directly reduce risks
associated with importing food into the United States. Specifically, we propose to develop and test
alternative technologies to greatly augment the availability of high-quality training opportunities using
the existing Produce Safety Alliance (PSA) curriculum and other training materials, such as the On-Farm
Readiness Review (OFRR), in support of the FSMA Produce Safety Rule (PSR). We will leverage the wide
availability of mobile telephones throughout the Americas and develop web- and application-based
training materials that not only incorporate requisite training per the curriculum but also provide easy
links to relevant portions of the rule and other important documents so that the user can refresh their
knowledge as needed. While a variety of training materials are available in English, we propose to
strengthen the reach and impact of existing and new materials by making them available in Spanish as
well. This approach will take advantage of the prevalence of access to mobile technology throughout the
Americas to create a group of tools that address the needs of adult learners and non-traditional
students. We will use well-tested approaches and learning techniques to ensure sustainable knowledge
building and understanding around FSMA implementation.
Working with partners in academia, we will design controlled experiments to test the efficacy of
alternative training materials against in-person training techniques to better understand what is and
what may be possible to achieve through alternative approaches. Using an iterative process, we will
develop alternative training materials, package them into new delivery methods, and test and validated
both the materials and delivery approaches through pilot projects. Based on the results of these pilot
projects, we will modify and further test our approaches, with the goal of releasing final, validated
products to a large, hemispheric audience. These “final” products will then be evaluated over the life of
the project to ensure their continued efficacy and provide inputs for corrective actions.
IICA is the specialized agency for agriculture within the Inter-American System. Counting on over
seventy-five years of experience and a network of over thirty offices across the Americas, IICA is an ideal
partner to support FDA to address technical capacity needs around FSMA implementation by foreign
governments and their industries in Latin America. IICA is and has been a strong U.S. government
partner in Latin America and the Caribbean for many years and has the demonstrated capacity to
implement FSMA training in the region.

Public health relevance
Project Narrative: IICA The Inter-American Institute for Cooperation on Agriculture (IICA) seeks to build on previous successes and implement high-impact interventions that directly reduce risks associated with importing food into the United States. Specifically, we propose to develop and test alternative technologies to greatly augment the availability of training opportunities using the existing Produce Safety Alliance (PSA) curriculum and other training materials, such as the On-Farm Readiness Review (OFRR), in support of the FSMA Produce Safety Rule (PSR). Leveraging the wide availability of mobile telephones throughout the Americas, we will develop web- and application-based training materials to increase access to high- quality training materials. Using an iterative process, we will develop alternative training materials, package them into new delivery methods, and test and validated both the materials and delivery approaches through pilot projects. Based on the results of these pilot projects, we will modify and further test our approaches, with the goal of releasing final, validated products to a large, hemispheric audience. While a variety of training materials are available in English, we propose to strengthen the reach and impact of existing and new materials by making them available in Spanish. Through this project, we will use well-tested approaches, new learning techniques, and robust evaluation to ensure sustainable knowledge building and improved understanding around FSMA implementation and compliance.